FUNCTIONAL INTERACTIONS AMONG BRAIN REGIONS IN AGING AND DEMENTIA

A correlation method was developed to examine functional interactions between brain regions, by correlating either regional cerebral metabolic rates for glucose or regional cerebral blood flows, as determined by positron emission tomography (PET) in humans. In humans in whom regional cerebral blood flow (rCBF) was measured with PET during a face matching task, correlations between visual brain areas and frontal regions were reduced in patients with mild dementia of the Alzheimer type (DAT) compared to controls. A rationale for use of neural modeling techniques with functional neuroimaging data was developed. A systems-level neural network model, fitted to rCBF PET data, permitted determination of the brain regions and their interactions that were involved in a working memory for faces task. A multiple regression/discriminant analysis involving PET regional interdependencies distinguished men and women on the basis of their inter- and intrahemispheric functional relations.